Impact of the MISSION Act on Quality and Outcomes of Interventional Cardiology and Cardiac Surgery among Veterans

Background: The implementation of the VA’s Maintaining Internal Systems and Strengthening Integrated
Outside Networks (MISSION) Act in June of 2019 greatly expanded opportunities for Veterans to be referred
outside of the Veterans Health Administration (VHA) for complex cardiac procedures and surgeries. However,
the VA has been a longstanding national leader in both interventional cardiology and cardiac surgical quality of
care. Hence, increased referrals outside of the VHA may reduce the probability that Veterans undergoing
cardiac procedures receive the highest care quality and the best procedural outcomes.
Significance/Impact: With increasing numbers of Veterans now eligible under the MISSION Act to obtain
major cardiac procedures outside VA, it is critically important for Veterans, their VA providers, and VA
operational leaders to fully understand the consequences of Veterans' choices in terms of their access to care,
quality of care, outcomes of care, and health care costs. The total costs of VA's Community Care program are
substantial; it is therefore essential that VA maximizes the value from funds expended on Community Care.
Innovation: The proposed research will extend prior studies comparing VA and Community Care provision of
major cardiac procedures with a specific focus on the impact of the MISSION Act, which has the potential to
vastly expand the number of Veterans receiving care outside VA. Our research will provide novel insight into
how Veterans’ choices between VA and non-VA providers could be better informed by information about health
care quality and outcomes of care, thus enhancing the decision-making process. Our cost analysis will identify
potential opportunities where better care coordination between VA and non-VA providers could improve both
the value of care delivered by eliminating gaps in, and reducing duplication of, services.
Specific Aims: The primary objectives of this study are to: (a) quantify the changes in use of VA and non-VA
cardiac surgery and interventional cardiology services resulting from the MISSION Act, with a focus on how
access to care was affected; (b) measure the effects of MISSION Act implementation on the rates Veterans
obtain cardiac surgery and interventional cardiology care from high-quality hospitals, and compare the risk-
adjusted post-procedure outcomes among Veterans obtaining cardiac procedures in VA hospitals or via
Community Care after the MISSION Act was implemented; (c) assess the effect of MISSION Act imple-
mentation on the cost of interventional cardiology and cardiac surgical care to both the VA and to Veterans.
Methodology: This study will leverage our research team’s substantial expertise with both VA and non-VA
clinical, administrative, and cost datasets. We will combine data from VA’s cardiac surgery and interventional
cardiology national registries with health care utilization, cost, and outcomes data housed in the VA’s
Corporate Data Warehouse, as well as VA’s Community Care datasets such as the Program Integrity Tool
database. We will focus on Veterans undergoing (1) percutaneous coronary intervention, (2) coronary artery
bypass grafting, (3) surgical valvular replacement, or (4) transcatheter aortic valve replacement. These are
among the most common major cardiac procedures performed among veterans, with substantial risk of
mortality and morbidity as well as high associated health care costs. We will assess the impact of the MISSION
Act on Veterans’ access to these procedures, the quality of cardiovascular care delivered by the hospitals
performing these procedures, the outcomes of care, and the costs to both VA and to Veterans.
Implementation/Next Steps: The project's overarching goals are to demonstrate the importance of quality
and outcomes information in making choices between health systems, and to identify opportunities for VA
leadership to improve care coordination, optimize clinical outcomes, and reduce costs in the Community Care
program. Our research team will work closely with our Operational Partners in the VA's Office of Community
Care and the VA's National Surgery Office to shape the VA Community Care Program’s future operations.

Public health relevance
The VA’s Maintaining Internal Systems and Strengthening Integrated Outside Networks (MISSION) Act of 2018 greatly expanded opportunities for Veterans to be referred outside of the VA for complex cardiac procedures. However the VA is a national leader in quality of care for advanced cardiac procedures, thus increased referrals outside of the VA may lower the quality of cardiac care, worsen clinical outcomes, and increase VA’s costs for Veterans receiving cardiac procedures. Our multi-disciplinary research team will use VA’s extensive national data resources on cardiovascular procedural care to examine the MISSION Act’s effect on health care access, quality, outcomes, and costs among Veterans receiving major cardiac procedures. The project’s overarching goals are to inform Veterans’ decisions regarding where they receive advanced cardiac care, improve care coordination, optimize clinical outcomes, and reduce costs.